Beyond Folate - a Supplementation Strategy to Prevent Neural Tube Defects

ABSTRACT
Diabetes during pregnancy increases the risk for structural birth defects, such heart defects
and neural tube defects. The widely held view is that the teratogen is the excess blood glucose
from the mother, because glycemic control in diabetic women is associated with lower birth
defects incidence. Numerous studies with rodent embryos cultured in the presence of high
glucose levels also have provided evidence for teratogenic action of glucose.
We have experimental evidence that structural birth defects in diabetic pregnancies are
caused by a glucose deficiency in embryonic cells: compelling transcriptome profiling data in
a mouse diabetes model indicate that embryos exposed to maternal diabetes experience
nutritional stress just as neural tube closure is about to commence. Intriguingly, a single bolus of
glucose could reverse diabetes-affected gene pathways towards normal, implying a nutrient
shortage, not an excess. Paradoxically, the diabetes-exposed embryo - despite the glucose-rich
maternal environment - appears to be in a state of nutrient deficiency.
In this exploratory project, we seek to investigate the biological significance of the glucose-
mediated reversal of diabetes-driven transcriptome changes. It is clear that treatment with
glucose is not a valid strategy in human diabetic pregnancies. However, we propose a treatment
strategy that addresses the nutritional deficiency by supplementing downstream
metabolites of glucose that (i) do not exacerbate the glycemic status of a diabetic mother, yet
(ii) relieve the nutritional deficit so that embryos in diabetic pregnancies may develop normally.
Therefore, this project falls into the NICHD priority area "Nutrition for Precision Health", by
directing nutritional prevention strategies at the cellular, molecular and metabolic abnormalities
that cause birth defects. We combine this approach with measurements designed to reveal the
influence of supplements on cell migration processes in the early embryo.
With this research, we provide a new perspective for developing approaches to reduce neural
tube defect incidence: by improving the ‘biochemical fitness’ of embryonic cells, we seek to
ensure accurate developmental performance. Such an approach may ultimately be useful to
prevent neural tube defects in general, not just those of metabolically distressed pregnancies.

Public health relevance
PROJECT SUMMARY Neural tube defects represent one of the most severe birth defects. While folate supplementation can reduce the incidence of neural tube defects, it cannot prevent all neural tube defects, thus highlighting the need for approaches that go beyond folate. Based on a model of diabetic pregnancy where neural tube defects are quite frequent, we seek to test a new strategy designed to improve the general biochemical fitness of cells of the developing embryo to ensure accurate developmental progress without incurring birth defects.